Administrative and Data Management Core

ABSTRACT ADMINISTRATIVE AND DATA MANAGEMENT (ADM) CORE
The PRECISION-AD ADM core plays several important roles in the functioning of the Center, and thus consists
of a team of individuals with diverse expertise in a variety of domains including in Alzheimer’s disease
pathogenesis, iPSC experimental systems, therapeutic development and testing, biomarker discovery, scaling
of iPSC-based systems, bioinformatics and computational biology, epidemiology, and large-scale open-science
sharing of resources. The core has four overarching responsibilities, which are outlined in the form of specific
aims. Under Aim 1, the ADM core provides oversight and administrative support within the Center to
ensure timely and efficient milestone completion. The ADM has delineated a series of specific milestones
and deliverables and will execute procedures for monitoring of progress and provide data-driven guidance for
go/no-go decisions. Under Aim 2, the ADM core will advise and guide the activities of the other three cores
based upon data, experimental resources and clinical trial data arising in the field. The ADM will work
closely with the Steering Committee and External Advisory Board to modify aspects of the approach based upon
data arising within the field and within the Center. Under Aim 3, the ADM core will support communications
between the Center and external researchers to both promote Center assets for external use and to
acquire externally generated resources for advancing core activities. Under Aim 4, the ADM core is
responsible for establishing an efficient pipeline for open distribution of all data, protocols, and cell
models developed within the Center. As PD of the project, Dr. Young-Pearse will be responsible for leading
the project as a whole and acts as the primary point of contact with the external advisory board (EAB) and NIH
program staff, including the submission of milestone reports to the NIH and EAB. In order to ensure the efficient
and robust meeting of milestones, each core head also is a MPI within the ADM core. Microphysiological
Systems Models Development and Validation (MPS) core PI, Dr. Young-Pearse will oversee the on-time
meeting of core milestones, which includes distribution of data to the Bioinformatic and Computational Biology
(BCB) core and distribution of cell model and assay protocols to the Preclinical Safety and Efficacy (PE&S) core.
PE&S core lead PI Paull is responsible for overseeing the timely completion of PE&S core milestones, which
includes scaling of assays, distribution of data to the BCB core, and establishment of pipelines for efficient
sharing of cell models. BCB core lead PI Carter is responsible for overseeing the completion of BCB milestones,
which includes the sharing of raw and processed data internally with all PIs through the ADM core. ADM MPI
Leal (Sage Bionetworks) is responsible for external sharing of the data generated with the scientific community.
ADM MPIs Bennett and Longo, who together have many decades of experience in studying AD pathogenesis
and the development and testing of interventional strategies, will provide essential advice and guidance on the
four aims of the ADM and of the overall scientific strategies and directions of the PRECISION-AD Center.